Interdisciplinary Training in Virology and Gene Therapy

DESCRIPTION (provided by applicant): Developments in virology have led to the development of several classes of therapeutics, including treatments or prevention of microbial infection and gene therapy. Gene therapy holds the promise of therapeutic options for a variety of diseases. A key issue in gene therapy is the development of gene delivery vehicles that evade immune or inflammatory response, are non-toxic, and target the gene effectively. To fulfill the national need for these types of therapeutic options, the UCLA Virology and Gene Therapy Training Program aims to provide a unique and outstanding environment for predoctoral and postdoctoral trainees pursuing research careers in fields related to gene therapy. This program will establish a solid training in fundamental virology and its applications in gene therapy. The research interests of our faculty encompass viral entry, viral gene expression regulation, replication of viral genome, cell biology during viral infection, viral particle assembly, viral carcinogenesis and viral immunology, as well as designing novel vectors and tracking viral vectors in vivo. With strong basic research programs on retroviruses, adenoviruses, SV40, hepatitis C, poliovirus, influenza virus and herpesviruses, our faculty has been and will be continuously developing viral vectors from these viruses and monitoring gene expression in vivo using non-invasive imaging technologies in combination stem cell biology. The trainees will be exposed to clinical and diagnostic issues during their training to underscore the therapeutic applications of their research projects, and be encouraged to form translational collaborations with basic and clinical mentors. This bridge in training environment will enhance the translation from basic science to clinical application in gene and cellular therapy. The training program constitutes 1) original research work with one or more of our faculty; 2) formal course work which provides comprehensive background on virology and gene therapy; and 3) regular research conferences and seminars, presented by invited guest speakers, faculty members and trainees; 4) training in best practices in research, responsible conduct and career development. The training committee will select trainees via a competitive process. Appointments are renewable with satisfactory progress (up to 2 years predoctoral, 1 year postdoctoral). The training program is fully integrated with the reorganized PhD programs in biosciences at UCLA. The progress of the trainees and the program are reviewed periodically. At UCLA, this rigorous training program with emphasis on vertical integration of basic sciences and therapeutic applications produces the scientists required for long-term development of virology and gene therapy.

Public health relevance
PUBLIC HEALTH RELEVANCE: Viruses cause a variety of diseases but their natural ability to deliver genetic materials into cells can be utilized to reprogram cells against inherited diseases, cancer, AIDS, and immune disorders. This training program is designed to produce future scientists in the fields of virology and gene therapy that will be able to develop antiviral drugs and vaccines, to design new, more effective viral vectors, understand how to apply these vectors to human diseases, and ensure that new therapies are available in the future.